Epigenetic mechanisms of anhedonia and fear in AUD

Summary/Abstract
The overarching hypothesis of the Center for Alcohol Research in Epigenetics (CARE) is that withdrawal from
chronic alcohol exposure produces cell-type specific epigenetic and transcriptomic changes that alter brain
function during the pathogenesis of alcohol use disorder (AUD). Further, we hypothesize that these cell-type
specific epigenetic and transcriptomic neuroadaptations promote maladaptive phenotypes that are common
following dependence and withdrawal. During the current funding period, we found upregulation of the epigenetic
modifier HDAC5 and genes associated with neuroimmune regulation: Stat3, Ptgs2, Irf7, Irf9, and Crhbp in the
hippocampus during withdrawal. Emerging evidence suggests dysregulated neuroimmune signaling in the
hippocampus affects its neuronal structure and function and contributes to AUD pathology as well as emergence
of comorbidities including depression, panic disorder and PTSD. This research project will investigate the role of
cell-type specific epigenetic and transcriptomic mechanisms regulating immune genes within the hippocampus
during withdrawal and mechanistically link these changes with withdrawal-induced increases in depression- and
fear-relevant behaviors associated with panic disorder and PTSD. In Aim 1, experiments will identify epigenetic
mechanisms driving transcriptional changes in genes identified from bulk RNA seq and ATAC-seq using
chromatin immunoprecipitation and qPCR. We will also translate these findings using human postmortem
hippocampus and determine the effect of HDAC5 inhibition of depression- and fear-relevant behaviors. In Aim
2, experiments will leverage the Epigenetics Core and single cell “10x genomics” strategies to identify cell-type
specific epigenetic and transcriptional changes following alcohol withdrawal in hippocampus. These studies will
confirm differential expression of genes identified in Aim1, identify new targets and improve spatial resolution of
our findings. In Aim 3, experiments will use CRISPR-mediated epigenetic editing will be used to reverse
withdrawal-induced cell-type specific epigenetic changes on specific genes identified in Aim 2. The same
approach will be used to rescue withdrawal-induced changes in depression-, panic disorder- and PTSD-relevant
behaviors, as well as glutamatergic neurotransmission using slice electrophysiology. The proposed experiments
integrate well with CARE’s core mission to understand epigenetic regulation of the molecular mechanisms
underlying neuroadaptations and behaviors associated with AUD. Together with the other components, these
studies form a comprehensive investigation of epigenetic mechanisms underlying AUD outcomes with strong
potential to reveal new targets for the development of pharmacotherapeutics aimed at treating AUD.

Public health relevance
Research Project 3: Project Narrative This proposal within the Center for Alcohol Research in Epigenetics (CARE) will determine if cell-type specific epigenetic mechanisms induced during withdrawal from chronic alcohol drinking in rats alter neuroimmune gene expression and neuronal function within the hippocampus. They will also determine if these mechanisms regulate withdrawal-induced increases in behaviors associated with comorbid disorders depression, panic disorder and PTSD. Results from these projects will improve our understanding of alcohol use disorder and its comorbidities, and lead to new epigenetic targets for treatment.